Molecular Mechanisms and Evolution of the Rhoptry Secretion System

PROJECT SUMMARY
This research program focuses on understanding the rhoptry secretion system in unicellular eukaryotes within
the Alveolata superphylum, including apicomplexan parasites and non-pathogenic ciliates. Apicomplexans,
such as Toxoplasma and Plasmodium, utilize rhoptry secretion for host invasion, a process with poorly
understood mechanisms.
Recent progress, utilizing cryo-electron tomography, uncovered a novel Rhoptry Secretory Apparatus crucial
for apicomplexan rhoptry secretion and host invasion. Similar machineries were found in ciliates, lacking the
apical vesicle, suggesting evolutionary adaptations.
The research program is structured around three main questions:
A) What is the conserved basic architecture of these secretion machineries?
Using cryo-electron tomography, the team will systematically image species across the Alveolata superphylum,
comparing apicomplexans and ciliates to understand architectural variations.
B) How are these machineries built?
Focusing on one model apicomplexan, Toxoplasma gondii, and one model ciliate, Tetrahymena thermophila,
the team will dissect and compare the detailed assembly of these secretion machineries using a combination
of genetics, structural biology, and proteomics approaches.
C) What is the mechanism for organelle content secretion?
The team will study structural changes of these machineries during active secretion events in both
apicomplexans and ciliates, utilizing innovative cryo-correlative microscopy and time-resolved sample freezing
methods to capture these spatially and temporally transient activities.
Capitalizing on the unique opportunity provided by the recent discovery of the Rhoptry Secretory Apparatus,
this comprehensive strategy integrates cutting-edge technologies and multidisciplinary approaches to unravel
the molecular structures, mechanisms, and evolutionary aspects of the rhoptry secretion system. The findings
will provide unprecedented and fundamental insights into molecular secretions in this prominent branch of
eukaryotic organisms for crucial biological functions.

Public health relevance
PROJECT NARRATIVE This project seeks to elucidate the intricate molecular mechanisms underlying a specialized secretion system found in unicellular eukaryotes, specifically in apicomplexan parasites and ciliates. Recent breakthroughs, such as the discovery of a unique molecular assembly governing secretion, pave the way for a comprehensive investigation into the system's structural basis and evolutionary aspects. By employing cutting-edge cryo- electron microscopy and a multidisciplinary approach, our research contributes to advancing fundamental knowledge in microbial cellular biology and molecular evolution.